ShEEP Request for A Namocell PALA Single CellDispenser

We are requesting a Namocell PALA Single Cell Dispenser, a benchtop instrument that
combines innovative microfluidics technology with flow cytometry and liquid dispensing. It can
sort and dispense single cells into 96 or 384-well plates in minutes. Its low-pressure operation (<2
psi) preserves cell viability as well as integrity. The ability to isolate specific cell populations is
invaluable for modern basic and applied biomedical research. Microfluidic droplet dispensers
provide for miniaturized, high-throughput isolation of single cells in a microenvironment, which
can be leveraged for ultra-sensitive and rapid assays. These units are ideal for a wide range of
single cell applications including cell cloning with improved outgrowth, generation of high-yield
single cell genomics libraries, rapid bulk sorting of specific target cells or rare cell populations,
and recovery of single cells from as few as 100 cells.
Single cell dispensers are currently in use in several academic and industry settings. Recent
acquisition of Namocell Single Cell Dispensers by federally supported facilities include
NIH/NIDA and Arkansas Little Rock VA. Data obtained with the PALA Single Cell Dispenser will
have applications for both cell culture as well as rodent model studies of human disease. As such,
we expect it will aid us in deciphering how these diseases develop or progress as well as help in
identifying new treatment opportunities for Veterans with these diseases.
The expected research applications for the Namocell PALA Single Cell Dispenser at JJP VAMC
will range from bulk sorting of homogenous cell populations to single cell isolation. Bulk sorting is
useful for initial interrogations of highly enriched, specific cell types. We expect JJP VAMC
investigators who use rodent models of human diseases including those with neurological, renal,
metabolic, or cancer relevance will use the PALA for bulk sorting of specific or rare cell
populations, particularly those residing in organs with heterogenous cell types [Major Users: JG,
CC, GP, RR]. Bulk sorting is also useful for identifying cells manipulated in culture that are marked
by fluorescent activity, such as transfected cells expressing specific fluorescent proteins (FP).
The dual laser system in the PALA will allow for selection of cells expressing dual exogenous
proteins with distinct FP surrogates without the need for prolonged drug selection, which
otherwise can introduce confounding factors [Major Users: JG, CC, RR].
The Namocell PALA Single Cell Dispenser will also be used for purification of single cells.
Single-cell analysis can discriminate signal from noise in a heterogeneous cell population and
thereby facilitate multiomic studies of rare cell populations obtained from tissues or blood of
healthy or disease animal models [Major Users: JG, CC, GP, RR]. The PALA will also facilitate
high-throughput isolation of single cells in a defined microenvironment, which can be leveraged
for ultra-sensitive and rapid assays [Major Users: JG, GP, RR]. Finally, we anticipate great
interest in the use of the PALA for cloning of precision genetically engineered transformed cells
or induced pluripotent stem cells (iPSC), which may offer insights into structure-function studies
as well as human disease contributions from nonsynonymous variants identified in human genetic
studies, respectively [Major Users: JG, CC, GP, RR].

Public health relevance
We request a Namocell PALA benchtop single cell dispenser for single cell studies, iPSC and CRISPR cell line engineering, antibody discovery, synthetic biology, and rare cell isolation. At our facility, specialized transformed cell lines and isolated primary cells are used extensively in cell culture and animal models of traumatic brain injury, spinal cord injury, Alzheimer’s disease, diet- induced obesity, diabetes, metabolic disease, renal disease, chronic anemia, and cancer, medical conditions of direct relevance to Veteran health concerns. The requested benchtop single cell dispenser will efficiently, reproducibly, and effectively isolate specific cells of interest from culture as well as rodent organs using engineered or endogenous cell-specific markers. The increased viability and quality of purified cells obtained by the Namocell PALA benchtop single cell dispenser compared to cells obtained by FACS will facilitate us fulfilling our stated research goals and will provide novel opportunities for current and future research endeavors.